Bicoastal Marmoset Breeding Center

Abstract/Summary
The common marmoset (Callithrix jacchus) has experienced unprecedented growth in research across the
United States and is rapidly emerging as a likely keystone biomedical model system in the next chapter of
scientific discovery. Over the past decade, the number of marmoset laboratories in the US has more than
quadrupled. There are now over 50 Principal Investigators who use marmoset as the model system in their
research. Neuroscience is the primary engine driving marmoset research today, as nearly three quarters of
marmoset researchers in the US use this model species to examine molecular, systems or cognitive functions
in normal and diseased brains. In the past few years, there has also been rapid progress in generating
genetically modified marmoset for disease models. In 2020, we established the Bicoastal Marmoset Breeding
Center with two breeding colonies, one on the East Coast at Johns Hopkins University (JHU) and the other on
the West Coast at University of California at San Diego (UCSD), to supply wild type marmosets to the research
community. Because of the non-availability of air transport of NHP in U.S. and prohibitively expensive ground
transportation of NHP between the east and west coast, these two breeding colonies are strategically located
to support the marmoset community in regions near each colony. In this application, we propose to expand the
mission of the Bicoastal Marmoset Breeding Center to increase the production of wild type marmosets to the
US research community as demand likewise increases and to breed genetically modified marmosets that are
produced by several NIH-funded projects and distribute these disease-model animals to investigators for their
research needs. In addition, we propose to establish methods for behavioral phenotyping of both wild type and
genetically modified marmosets in their social housing environment and make these methods available for the
marmoset research community.

Public health relevance
Public Health Relevance Statement: A proper model system is crucial to advance the studies of human neuropsychiatric diseases. The proposed project will contribute to the research in this field by making critical resource available to neuroscience research community.